"Outside-in” Model of Cardiac Pacemaking: Extracellular Mediated Automaticity

Abstract
The heart’s native pacemaker complex, the sinoatrial node (SAN), is a multicellular bioelectric signaling center
responsible for rhythmically initiating the impulses that drive cardiac contraction. SAN dysfunction is extremely
prevalent in humans and represents one of the leading causes for the surgical implantation of artificial pacing
devices. SAN dysfunction is a progressive and noncurable. To date the molecular pathophysiology of SAN
dysfunction remains poorly understood. Indeed, significant gaps remain in even our basic understanding of the
biophysical processes that control electrical impulse generation in the heart. This is compounded by the fact that
major discrepancies still exist between our theoretical descriptions of SAN electrical activation and experimental
data. Therefore, we have used a combination of in vivo experimentation and computational modeling to
reevaluate fundamental principles of cardiac pacemaking. More specifically, we have modeled how extracellular
ion dynamics can influence the behavior of excitable cells arranged within fixed tissue geometries. This has
revealed that robust entrained automaticity can emerge within cellular networks through repetitive
elevation/depletion of extracellular potassium [K+]o. The stability of this automaticity is highest when [K+]o is
elevated within diffusion limited extracellular nanodomains that are accessed by multiple cells. In addition, our
model predicts that entrained automaticity can be achieved even when not all cells within a population are
natively autorhythmic or connected via gap junctions. We have termed this form of “outside-in” regulation of
pacemaking Extracellular Mediated Automaticity (EMA). In support of our computational simulations we have
localized [K+]o within intact embryonic SAN tissue and identified that: i) [K+]o is indeed elevated in nanodomains
between adjacent cardiac pacemaker cells (CPCs) in the SAN, ii) [K+]o oscillates within these nanodomains in a
manner predicted by EMA, and iii) depletion of [K+]o from these nanodomains results in rapid loss of SAN
automaticity and entrainment. Collectively these data have led to our overall working hypothesis that extracellular
ion cycling serves as a baseline mechanism for imparting rhythmic, multicellular, impulse generation in the SAN.
This hypothesis will be tested across two specific aims in which we will define [K+]o as the critical ionic species
that underlies this form of entrained CPC automaticity (Aim1) and identify the mechanisms that control
nonuniform extracellular ion distribution within the SAN (Aim2). Thus, successfully completion of the proposed
studies will uncover an entirely novel set of paradigms for coupled electrical oscillation in the SAN and identify
new extracellular regulators of SAN function. These data will fundamentally alter current theories of cardiac
pacemaking, identify new factors to target as causative for SAN dysfunction, and directly inform future design
criteria for clinical restoration of homologous biological pacemaking in patients.

Public health relevance
Project Narrative Sinoatrial node dysfunction represents a significant clinical burden in the US and is the leading cause for surgical implantation of artificial pacemakers. This proposal seeks to test a novel model of normal sinoatrial function in order to resolve major outstanding inconsistencies in the field. Successful completion of these studies will uncover the role that extracellular ionic fluctuations paly in pacemaking, define how extracellular matrix composition influence SAN activity, and provide critical insight for the design of next-generation of therapeutics for correcting human arrythmias.